Amplifying and Redirecting CMV-specific CD8 T cells to provide sustained control of HIV infection

The immune system of HIV-infected individuals is unable to eliminate latently infected cells following reactivation,
resulting in the recurrence of viremia after stopping antiretroviral therapy, preventing functional cure. This
necessitates lifelong ART for people with HIV (PWH). New strategies are needed to mobilize the immune system
to prevent the emergence of HIV from the HIV reservoir after ART cessation. We recently developed synTacs,
infusible immunostimulatory biologics consisting of dimeric Fc-domain scaffolds linking MHC molecules and
virus-derived peptides (c-pMHC) capable of delivering antigen-specific TCR-signals and ligands that supply
defined costimulatory signals. We demonstrated that synTacs bearing CMV-derived peptides, and anti-CD28
scFv or 4-1BBL signaling modules, stimulated vigorous and selective ex vivo and in vivo expansion of highly
polyfunctional CMV-specific CD8+ T cells in PWH PBMC, which displayed potent in vivo anti-CMV activities. We
also recently described the potent in vitro and in vivo anti-HIV activity of CAR-T cells that use a novel two-
molecule duoCAR architecture to co-express two independent CARs, each recognizing a distinct gp120 epitope.
HIV-specific T cell responses or CAR-T cell treatments fail to provide sustained control of HIV infection because
of the eventual reduction or loss of their functional anti-HIV activity, even in the absence of mutational immune
escape. In contrast, CMV-specific T cell responses consist of effector memory CD8 T cells that maintain their
capacity for cytokine release, killing and proliferation and actually expand over time, a phenotype described as
memory inflation. We hypothesize that combining the capacity of synTacs to activate and markedly expand CMV-
specific CD8 T cells with novel strategies to redirect them to eliminate HIV-infected cells, would exploit the highly
functional and resilient CMV-specific CD8 T cell responses to provide improved immune control of HIV infection.
We propose to combine the capacity of synTacs to selectively activate and markedly expand CMV-specific CD8
T cells with potent and sustained anti-viral activity with three Specific Aims (SA) to redirect them to target HIV-
infected cells. We will either convert the expanded CMV CD8 T cells into HIV-specific CAR T cells (SA 1), or
anti-HIV T cells (SA 2), or modify the synTac structure to link CMV-c-pMHC, gp120-binders and costimulatory
ligands, to both fully activate and direct CMV CD8 T cells to target HIV-infected cells (SA 3), thereby mobilizing
an in vivo immune response that controls HIV infection, eliminates reactivated latently infected cells and provides
sustained ART-free remission of HIV infection to PWH. Furthermore, we will also utilize synTacs delivering
defined costimulatory signals, to extend our knowledge regarding the capacity of different costimulatory signals
to generate the most potent CD8+ T cells and CAR-T cells for eliminating reactivated latently infected T cells.

Public health relevance
Despite years of effective suppressive antiretroviral therapy (ART), latent HIV-infected cells can persist in people with HIV (PWH) and reintroduce disseminated HIV infection after cessation of ART, preventing the functional cure of HIV-infected individuals. The anti-HIV-1 immune response in most patients is inadequate to effectively eliminate reactivated cells, necessitating the development of strategies to boost the anti-HIV immune response to enable it to clear the reservoir after reactivation. We postulate that by redirecting CD8 T cells that are highly effective in controlling chronic latent CMV infection to target and kill HIV-infected cells, we can boost the HIV- specific immune response in PWH to prevent recurrent viremia after the cessation of ART and contribute to providing a functional cure of HIV infection.